Defining the role of haplotypes and rejection pathways in placental villitis

PROJECT SUMMARY
Chronic villitis of unknown etiology (VUE) is commonly diagnosed in the placenta and key features during
histologic evaluation are the infiltration of T lymphocytes into the villous parenchyma and corresponding
trophoblast necrosis. VUE is seen in the context of adverse fetal outcomes (i.e., fetal growth restriction, NICU
admission, neurodevelopmental delays) and seemingly normal outcomes. As our understanding of the cause
of this inflammation is not well defined, it is difficult to understand the spectrum of fetal outcomes associated
with a VUE diagnosis and develop useful clinical management strategies which could be employed during
pregnancy to positively impact health. The current hypothesis for VUE is that it represents a breakdown of
immunologic tolerance to the fetal allograft resulting in maternal T cell targeting of paternal (fetal) antigens in
the placenta. We and others have previously shown that there are histologic and immunologic changes
associated with villitis, specifically as it relates to human leukocyte antigen (HLA) expression; however, we still
cannot predict or prevent VUE from harming a fetus, which is particularly significant for couples worried about
recurrent villitis. Therefore, this study aims to provide stronger evidence to delineate the immunology of VUE
based on severity and immune mediated rejection pathways. Our hypothesis is that VUE represents an
immunogenic pathology resembling organ rejection and that certain maternal-infant HLA types lead to
increased risk of disease and poor fetal outcomes. We will address this hypothesis in two Specific Aims: 1)
evaluate the associations between maternal-infant haplotype and VUE (adverse fetal outcomes vs. normal
outcomes); and 2) determine whether VUE placentae have activation and upregulation of organ rejection
genes/pathways in the absence of infectious stimuli. By studying the underlying VUE pathogenesis associated
with positive and negative fetal outcomes, we will be able to discover better therapeutic targets, create
valuable risk stratification tools and even identify biomarkers of placental inflammation which could be used to
manage VUE in utero and prevent the poor neonatal outcomes associated with this pathology.

Public health relevance
PROJECT NARRATIVE Inflammation in the placenta can cause harm to the developing baby, but often has no explanation as to why it happened. Our goal is to discover what might be prompting this inflammation to cause to poor outcomes in the baby. Understanding this could help physicians and patients achieve healthier pregnancies.